A Digital Intervention to Reduce Youth Cannabis Use

Project Abstract
This SBIR Phase I application, titled "A Digital Intervention to Reduce Youth Cannabis Use," aims
to create a novel mobile cannabis intervention for youth aged 13-17 who are using regularly. This
tool is designed to work in conjunction with existing support systems, including traditional
treatment, individual therapy, or school-based support. Given the association between regular,
high-potency cannabis use and a range of adverse outcomes in young people—such as
depression, suicide, psychosis, cognitive decline, hospitalizations, and traffic accidents—
innovative approaches are necessary to align with youth culture while promoting health and well-
being. However, there are few empirically informed mobile health cannabis solutions
commercially available to young people, and to our knowledge, none for adolescents 13-17. To
address this gap, we propose to develop the "Adolescent Clear30," which will leverage the basic
framework of our 18+ Clear30 mobile program as a foundation, offering a suite of tailored tools
informed by the literature and our participatory design methods. The proposed intervention will
include adolescent-tailored personalized feedback, daily communications (via texts and push
alerts) for up to six months, guided meditations, resource pages, multimedia content, optional
asynchronous human support, and an AI-driven chatbot. We will also develop a parent support
guide to align with A-Clear30 goals. To develop a comprehensive A-Clear30 intervention, we will
perform an extensive literature review, develop an assessment instrument informed by the CUD
intervention literature, existing Clear30 frameworks, and hyper-tailoring methodologies. We will
then perform a remote study involving 40 young individuals diagnosed with Cannabis Use
Disorder (CUD), their guardians, and 10 clinicians with domain-specific expertise to develop
intervention content tailored to user characteristics. In addition, we will update our existing AI
chatbot for under-18 users, enhancing cultural sensitivity. Based on this research, we will develop
a Minimum Viable Product (MVP) spanning both mobile and SMS platforms, complemented by a
concise Parent Support Guide. We will test the MVP's content, functionality, design, and user
experience with selected adolescent and guardian cohorts, quality assurance specialists, and
subsequent refinements for a beta release, ensuring the product's alignment with user needs.
This participatory design process, which engages both users and stakeholders, will guide iterative
development, ensuring the MVP's effectiveness and broad appeal. If successful, this would
become the first commercially available mobile support service tailored to the diverse needs and
goals of adolescents who use cannabis with an adjunctive parent support guide.

Public health relevance
Project Narrative In response to the increasing prevalence of regular cannabis use among adolescents, this Phase I intervention development research is designed to create the world's first commercially available mobile cannabis intervention for young people aged 13-17. If successful, this project could assist adolescents in reducing or ceasing regular use and the associated consequences, including depression, suicide, psychosis, school dropout, and addiction, among others. It can also contribute to the establishment of best practices in digital cannabis intervention development research for adolescents and support clinicians by providing an adjunctive mobile support service.